Washington University Psychiatry Residency Research Education Program

PROJECT SUMMARY/ABSTRACT
Despite increased funding across the NIH enterprise over the past decade, fewer physician trainees are choosing
to pursue scientific careers, contributing to a decline in the number of physician-scientists capable of achieving
independent research success. To address the workforce needs, the Department of Psychiatry at Washington
University launched the Psychiatry Resident Research Education Program (PRREP) in 2016. Funded by NIMH’s
R25 program in 2017, PRREP is agnostic of prior research experience, is available to both our general and child
and adolescent psychiatry (CAP) training programs, and provides individualized educational planning divided
into two phases. Phase 1 aims to increase the number of incoming residents considering a research career by
enhancing recruitment and providing early education (career counseling/mentoring, didactics, seminars, on-line
coursework) and introductory research experiences. The more research-intensive Phase 2 focuses on gaining
experience in key areas, including study design, regulatory considerations, budgeting, data
collection/management, and analysis. Total time spent in hands-on research will be approximately 12 months
for a resident in the 4-year general adult program and 13 months for a CAP resident who is in training for 5 years.
During this first period of funding, our PRREP graduates have been a diverse group of individuals (10% disabled,
13% Hispanic, 13% African American, 42% female) and we have doubled the number of graduates pursuing
research careers (50% with a Ph.D.). Our PRREP trainees have been listed as an author on manuscripts 101
times. In this renewal application we seek on-going support from NIMH’s R25 program to expand on the early
successes we have achieved with this critical program, building upon the solid foundation we have established
in these first 4 years. In this renewal application, we propose to continue to recruit promising trainees into
PRREP, providing early and focused mentorship and hands-on research experiences to promote development
of skills and knowledge necessary for successful transition to Phase 2. To build upon the success achieved
during the initial funding period, we will focus on the following goals: 1) we will target recruitment of individuals
interested in CAP research careers, provide early exposure to CAP faculty and enhance the mentorship of
trainees interested in CAP; 2) utilizing institutional training and support resources, we will promote excellence in
mentorship by providing mentors feedback throughout the academic year, and provide mentorship training and
support for early-career faculty with emerging mentoring skills; and 3) informed by the initial 4 years of funding,
we will develop, implement and track educational milestones targeting research skills needed to become a
successful principal investigator. Funding for the next 5 years will provide us with the means to build on this solid
foundation to continue providing innovative and inclusive research training for the next generation of physician-
scientists in psychiatry.

Public health relevance
The proposed renewal application seeks to build upon the past success of the currently NIMH R25 funded Psychiatry Residency Research Education Program (PRREP). The goal of PRREP is to enhance the recruitment and training of psychiatrists for a career in academic psychiatry in order to meet the increasing shortage of physicians who conduct research in mental health and mental disorders. Training will focus on basic neuroscience, clinical science, imagining, genetics, public health, and epidemiology but can be in any area that impacts mental health and illness.